Probing the Structure/Function/Dynamics Relationship in Biomolecular Complexes with Multiscale Computational Techniques

Project Summary:
Over the last two decades, enabled by progress in synchrotron radiation techniques, molecular biology
methods, and computational resources, there has been tremendous progress in determining the
conformations of biomolecules that has led to deep structural and functional insights. But there is another
dimension to biological function, namely dynamics, which is, as yet, underexplored. This has created a
serious blind spot that inhibits progress towards a full understanding of macromolecular functions and
biological processes. The broad objective of this proposal is to utilize and develop computer simulations
that address this deficiency in knowledge by rigorously modeling biomolecular dynamics to increase our
understanding of biological processes. More specifically, we will pursue three interrelated projects. First,
we will determine how chromatin remodeling factors influence the dynamics of nucleosomes and
chromatin fibers as a means of epigenetic gene regulation. Second, we will examine the mechanisms of key
virulence factors in bacteria, including how they scagence iron from hosts and how they defended
themselves from peptidomimetics. Finally, we will develop computational methods that more effectively
model the results of solution small angle X-ray scattering experiments for diverse biomolecular complexes.
Completion of these studies will reveal intricate details about the relationship between the structure,
function, and dynamics of multicomponent biomolecular complexes across a vast range of time and length
scales. Furthermore, the synergy between the scientific goals, as well as the computational methods and
strong experimental collaborations in each of these projects, will foster new opportunities and areas of
scientific inquiry that the MIRA award will allow us to pursue. Overall, this work will address a series of
fundamental gaps in knowledge for critical biological processes, and will lay the foundation for future
studies that will improve the treatment and prevention of human ailments.

Public health relevance
PROJECT NARRATIVE The biological functions of proteins and nucleic acids is a result of both their three-dimensional structure and their conformational dynamics. In this work, computer simulations are utilized to explore and quantify these dynamic properties, as well as how they are linked to the function and regulation of biomolecular complexes. Specific projects will provide a basis for how dynamics affect DNA condensation and gene expression in chromatin fibers, the molecular mechanisms of heme extraction by Gram-positive bacteria, how synthetic peptide-mimics interact with the outer membrane of Gram-negative bacteria, and how experimental small angle X-ray scattering experiments can be interpreted to better understand the structure/function/dynamics relationship in diverse biomolecular complexes.